Patterning human forebrain organoids by engineering controlled biochemical microenvironment

PROJECT SUMMARY
Brain organoids are becoming powerful tools to study fundamental mechanisms underlying human brain
development and neurological disorders and have the potential to be used as a high-throughput platform for
therapeutic screening. However, current state-of-the-art brain organoids suffer from limited reproducibility,
scalability, and structural accuracy, thereby preventing their broader applications. It is, therefore, challenging to
study the diverse cell biology, maturation, and functional interactions (circuitry) among different brain
subdivisions. Importantly, current brain organoids lack proper polarity with accurate anterior-posterior (A-P)
and dorsal-ventral (D-V) spatial patterning. Recent studies and our preliminary results strongly suggest that the
extrinsic concentration gradient of morphogens can effectively pattern brain organoids. Here, we aim to
efficiently and reproducibly impose such morphogen gradients to human pluripotent stem cell aggregates by
developing two novel microdevices that can generate sustained and customized morphogen concentration
gradients. Specifically, we will first develop a microfabricated device to produce antiparallel gradients of Wnt
inhibitor, and BMP7 and MER/ERK inhibitor based on localized passive diffusion (referred to as LPaD 2.0). We
will use this device to pattern human forebrain organoids (hFOs) along the A-P axis (Aim 1). Then, we will
develop an array of Hydrogel Microneedles (HM) to deliver small molecules directly to the inside of the
organoids and combine the HM device with the LPaD 2.0 device to generate orthogonal gradients to induce
simultaneous A-P and D-V patterning in hFOs. In addition to morphogen gradients, we will also evaluate the
effects of organoid shape and nutrient/oxygen presentations on the hFOs development by changing the design
of the HM device. We will characterize the cytoarchitecture and function of the hFOs derived from these
devices by immunocytochemistry, single-cell RNA sequencing, and high-density multi-electrode array analysis.
The reproducibility and yield of our system will be quantitatively compared with conventional methods for
deriving hFOs and the functional states will be benchmarked with the state-of-the-art assembloids models
using the interneuron migration assay and thalamic project assay. The goal of this project is to advance the
biomanufacturing of organoids by providing easy-to-use devices to reproducibly produce complete or region-
specific brain organoids with proper patterning. Our devices have the potential to be applied to other organoid
systems. The fully patterned hFOs offer a versatile model to better dissect the cellular and tissue scale
features of neurological diseases, such as schizophrenia and autism, and have the potential to be used as a
drug screening platform to improve the treatment strategies for these diseases.

Public health relevance
PROJECT NARRATIVE Current brain organoids suffer from limited reproducibility, scalability, and structural fidelity, thereby preventing their broader applications in studying human brain development and mechanisms underlying neurological diseases. Here we leverage bioengineering and stem cell biology to combine rationally designed microdevices with the innate self-organizing capability of human pluripotent stem cells to generate a reproducible, scalable, and predictable next-generation forebrain organoid system that will closely resemble the physiology of in vivo human forebrain development. Results from the completion of this grant will provide novel insight and potential strategies for cell-based applications in regenerative medicine and therapeutic development.